CLINICAL TRIAL OF N-(4-HYDROXYPHENYL)RETINIMIDETHE

Conduct phase II clinical trials of chemopreventive agents. Provide the drug development data to allow approval of the drug for clinical chemoprevention studies.